Machine Learning Powered Platform for Discovery of Peptide Ligands for Peptide-Drug Conjugates

Project Abstract
Peptide drug conjugates (PDCs) are an emerging approach for targeted cytotoxic delivery, offering higher tumor
penetration and lower manufacturing costs compared to antibody-drug conjugates (ADCs). However, the
discovery and optimization of PDCs remains inefficient due to the linear nature of peptide hit-to-lead workflows.
Existing peptide discovery methods, such as phage or mRNA display not only require several enrichment cycles
but yield hits that lack selectivity and stability resulting in additional time for downstream optimization. Moreover,
data from display techniques suffer from high false positive rates, lack of negative controls, and amplification
biases, limiting their utility for machine learning (ML)-driven improvements. To address these challenges, we
propose to join the complementary strengths of Robust Dx’s peptide microarray expertise and Koliber’s ML
optimization capabilities to create a next-generation peptide discovery system capable of identifying PDC leads
within three months. The proposed discovery platform utilizes a peptide array designed for enhanced protease
stability through the incorporation of mixed L- and D-amino acids, with sequences selected using unsupervised
ML approaches to achieve high diversity and uniform coverage of the design space. The platform utilizes
advanced assays developed by RobustDx to accurately measure target and off-target binding while also
estimating kinetic parameters. Preliminary modeling by Koliber using random, L only array datasets shows
feasibility of ML model training and ability to discover distinct binding patterns enabling rational selection of
diverse hits. In this Phase I proposal, we aim to demonstrate that the designed peptide arrays can effectively
identify stable and specific binders to a promising PDC target, Nectin-4. Furthermore, we will show that the
discovery data can be utilized to train ML models to further optimize potency and specificity. In Aim 1 we will
produce a 2,000-peptide microarray of mixed L- and D-amino acids and discover hit peptides for Nectin-4. In
Aim 2 we will validate the hits via SPR for potency, selectivity and evaluate serum stability. And in Aim 3 we will
demonstrate that we can use ML models trained on the discovery data to improve the hits to achieve sub µM
KDs and over 5-fold specificity. Successful completion of Phase I will establish the feasibility of a system that can
rapidly and reliably result in protease stabilized, highly selective and potent PDC leads. In Phase II we will further
improve the library designs, refine the ML models to enhance prediction accuracy and begin to commercialize
the platform through partnering with biopharma companies to address a broader range of targets and advance
novel PDC candidates to the clinic.

Public health relevance
Project Narrative Peptide drug conjugates (PDCs) are a promising new class of therapeutics well suited for targeted delivery of cytotoxic compounds with lower toxicity and improved efficacy versus systemic treatments. However, discovery and development of the targeting peptide is slow and difficult. In this proposal, we will develop a new platform that discovers and in parallel develops advanced hits, shortening the development time and cost of next generation PDCs.